Mechanisms of Regulation of Neuronal GPCRs by KCTDs

Abstract
Neuromodulatory GPCRs are critical regulators of neuronal activity that function within complex networks of
accessory proteins which shape their signaling across space and time. Proteins in the potassium channel
tetramerization domain (KCTD) family are important accessory subunits of the GABAB receptor, serving to
regulate the intensity and duration of signaling in response to the inhibitory neurotransmitter, GABA. However,
a mechanistic understanding of KCTD regulation of GABAB receptors is lacking and whether KCTDs regulate
other neuromodulatory GPCRs is unknown. In aim 1, we will investigate GABAB receptor/KCTD coupling at the
molecular level, using a combination of structural studies by cryo-electron microscopy and biophysical analysis
in vitro. In aim 2, we will probe the cellular mechanisms of KCTD regulation of GABAB receptor signaling with
functional studies by electrophysiology and fluorescence microscopy and proximity labeling mass spectrometry
both in cell lines and primary neurons. In aim 3, we will build on preliminary data identifying the M5 muscarinic
acetylcholine receptor as a novel KCTD target by characterizing this novel signaling complex using in vitro
biochemical and biophysical techniques and live cell functional assays. Collectively, the results of this study will
serve to develop a detailed mechanistic understanding of KCTD modulation of GPCR signaling as well as laying
a foundation for investigation of newly discovered regulatory proteins and signaling components. Proposed
technology development efforts may also find broader utility in other areas of molecular neurobiology, further
enhancing the potential impact of this work.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) Precise regulation of G protein-coupled receptor (GPCR) signaling is essential for proper function of the nervous system. KCTD proteins are a family of critical regulators of GPCR signaling in the brain, and they have been implicated in a variety of neuropsychiatric diseases including mood disorders. A detailed understanding of KCTD protein function is important both for understanding fundamental human biology and for its relevance to human disease.